Modeling Homeostasis of Human Blood Metabolites

PROJECT SUMMARY
Metabolite levels in human blood are regulated by a relatively strict system of homeostatic control. Previous
investigations of homeostasis have taken a number of approaches, and models of glucose and a few other
metabolites have been developed, typically focused on a single organ. However, while potentially extremely
useful, an accurate and quantitative model of blood metabolite levels under homeostasis does not currently exist.
It is well known that numerous demographic and clinical factors such as gender, age, BMI, smoking, etc., as
well as pre-analytical factors and many diseases, significantly affect the levels of blood metabolites. Numerous
studies in the field of metabolomics have attempted to account for the effects of many such factors. However,
efforts to quantify these effects and validate them across different studies have so far been challenging, and
resulted in consistent failures to validate discovered putative biomarkers. The challenges to integrate metabolite
profiles with clinical and demographic factors are complicated by the high dimensionality of the data and the
numerous correlations among the metabolites. Traditional statistical methods are incapable of accounting for
these factors, and hence, investigations suffer from a high false discovery rate (FDR).
To overcome these challenges, we propose to develop quantitative statistical models of blood metabolite
levels in healthy adults, and thereby produce a predictive model of homeostasis. Our preliminary work indicates
that we can predict metabolite levels with much reduced variance using the reproducibly measured levels of a
large pool of blood metabolites and clinical and demographic variables. We propose to develop sophisticated
models of homeostasis based on advanced statistical methods and evaluate their predictive performance across
different sample sets and metabolite classes.
The proposed project has four main Aims: (1) Obtain broad-based metabolomics data on blood samples
collected from geographically distinct sites to explore the effects of a range of confounding effects on metabolite
levels. (2) Model individual or biologically related groups of metabolite levels using multivariate statistical
approaches to determine the contribution of clinical/demographic and pre-analytical variables and their
predictability across collection site. (3) Investigate the interactions between metabolites and clinical/demographic
variables using machine learning approaches to identify stable metabolites and key interactions. (4) Provide the
community with user-friendly software packages for the prediction of blood metabolite levels under homeostasis.
An overall model of the metabolite concentrations in blood will be highly useful for a number of applications
that include a better understanding of systems biology at the whole organism level, and ultimately improved risk
prediction, disease diagnosis, treatment monitoring and outcomes analysis.

Public health relevance
PROJECT NARRATIVE A quantitative model of blood homeostasis based on predicting the normal levels of small molecules in the blood can help identify diseases or other stresses that cause changes to those levels. The proposed statistical methods that will be used to develop this homeostasis model have the potential to efficiently identify more reliable disease markers and to more accurately predict disease risk.